The role of ADAM9 in retinal health and disease

PROJECT SUMMARY/ABSTRACT
The overall goal of this proposal is to identify the pathophysiological mechanisms underlying photoreceptor
degeneration caused by mutations in ADAM9 (A Disintegrin And Metalloproteinase 9) in human and canine
patients. Previous work in mouse and canine models has revealed that loss of ADAM9 leads to disruptions in the
interface between the photoreceptor outer segments and the retinal pigment epithelium (RPE). Preliminary data
for this proposal reveal a substantial accumulation of extracellular material from the interphotoreceptor matrix at
this interface. Given the well-established roles of ADAM proteins as both proteases and cell adhesion molecules,
this project will explore two not mutually exclusive hypotheses: (1) ADAM9 functions as a protease regulating the
composition of the interphotoreceptor matrix and (2) ADAM9 functions as a cell adhesion molecule forming
contacts between the photoreceptor outer segments and RPE. These hypotheses will be tested using a variety of
genetically modified ADAM9 mouse models. In Aim 1 of the mentored phase, the global ADAM9 knockout mouse
will be comprehensively characterized using a variety of techniques that will provide new training opportunities to
the candidate. In Aim 2 of the mentored phase, the candidate will train in high-end proteomic techniques to
analyze the composition of the interphotoreceptor matrix on both qualitative and quantitative levels.
In the independent phase, this training will be applied to test two complementary hypotheses on the function of
ADAM9 in the retina. Aim 3 will explore the hypothesis that ADAM9 proteolyzes interphotoreceptor matrix
components, whereas Aim 4 will explore the hypothesis that ADAM9 functions as a cell adhesion molecule. Given
that ADAM9 is expressed by both photoreceptors and the RPE, the experiments in Aim 5 will identify the cell type
primarily responsible for ADAM9-associated pathology. Taken together, the proposed studies will guide future
therapeutic efforts for cone-rod dystrophy patients bearing ADAM9 mutations. Additionally, given the critical
roles of the interphotoreceptor matrix in supporting the integrity of the outer retina and retinal adhesion to the
RPE, this proposal will provide broader insights into retinal diseases such as retinal detachment and some
forms of retinitis pigmentosa. The training in experimental approaches provided by the proposed research will
be supplemented with career development training at Duke University, including formal coursework, in both
communication skills as well as mentoring and leadership skills. The candidate will be mentored by Dr. Vadim
Arshavsky, a leader in the field of retinal cell biology and a highly accomplished mentor who has successfully
launched the careers of over a dozen faculty members, most of whom are funded by the NIH. Ultimately, this
training will allow the candidate to achieve his long-term goal of becoming an independent investigator
studying the biology of the visual system and pathophysiology of retinal disease.

Public health relevance
PROJECT NARRATIVE Mutations in the ADAM9 gene lead to loss of vision in human and veterinary patients. The proposed research utilizes genetically modified mouse models to address the pathophysiological mechanisms underlying photoreceptor degeneration due to the loss of ADAM9. Identifying these mechanisms is critical for developing therapeutic interventions aiming to prevent vision loss in affected patients.